Symp on "Aging Non-human Primates: Models, Progress & Future Directions" wkp

[unreadable] DESCRIPTION (provided by applicant): NOT PRESENT IN ORIGINAL APPLICATION [unreadable] [unreadable] [unreadable]